IGF::OT::IGF SURVEILLANCE EPIDEMIOLOGY AND END RESULTS (SEER): AJCC SUPPORT FOR UICC COLLABORATIVE EFFORTS AND AJCC 8TH EDITION TRAINING SUPPORT

The purpose of this contract includes 1) support for a collaborative effort between the AJCC and the Union for International Cancer Control (UICC) for the purpose of harmonizing anatomical staging criteria on a global level with the goal of enabling international cancer registry reporting by stage, and 2) support of NCI SEER Program training needs for the AJCC 8th Edition TNM Cancer Staging Manual.